Administrative Core

PROJECT SUMMARY: Administrative Core
The purpose of the Administrative (Admin) Core of the Building and InnovatinG: Digital heAlth Technology and Analytics (BIGDATA) Core Center for Clinical Research (CCCR) is to purposefully focus and prioritize efforts of the center on the most meritorious and highest impact science within the National Institute of Arthritis and Musculoskeletal and Skin Diseases (NIAMS) mission. Centered around our main theme of informatics, ‘big data’, and real-world evidence; the Admin Core will ensure that the infrastructure and educational needs of our user base of researchers and trainees are met; and facilitate knowledge translation and dissemination of our user base’s findings to the research community, patients, clinicians and policy makers. The Admin Core will work closely with both the Methods and Health Informatics (MHI) core, with its focus on biostatistics, informatics, and technology, and a new Dissemination, Implementation, and Community Engagement (DICE) Resource core to execute on our sub-theme of community engagement. The Admin Core aims to: Aim 1: Facilitate the coordination, evolution and expansion of the highly successful MHI Core and a novel Dissemination, Implementation and Community Engagement (DICE) Resource Core. To ensure that our users have access to a vigorous intellectual and scholarly research environment, the Admin Core will coordinate and provide a gateway to our existing and refined services, facilities, applications, and innovative research projects leveraging the unique strengths of the CCCR investigators and user base using state-of-the-art tools from rheumatology, informatics, statistics, epidemiology, implementation and dissemination science, and outcomes research; Aim 2: Oversee the continuation of outstanding educational enrichment programs designed to bolster the knowledge and skills of the user base to promote high quality clinical and informatics research and leverage institutional resources such as the National Center for Advancing Translational Sciences (NCATS)-funded UAB Center for Clinical and Translational Science (CCTS); Aim 3: Foster the development of Pilot and Feasibility project program and provide oversight and management for these projects; and Aim 4: Coordinate interactions between the CCCR Executive, Patient, and Internal and External Advisory Committees, and existing UAB entities such as the UAB CCTS; and evaluate progress on the overall strategic agenda of the Center and our three Cores by a) ensuring goals are met according to key performance indicators regarding leadership, engagement and the quality of services and resources provided by BIGDATA to the user base, and b) quantify BIGDATA’s impact on the rheumatologic, musculoskeletal, and skin disease research community and relevance to our theme and subtheme. BIGDATA’s goal is to provide state-of-the-art data capture tools, visualization methods and analytic strategies that can be leveraged by arthritis, musculoskeletal, and skin disease researchers, with an emphasis on community engagement.